Modulation of serotonin levels during development produce long-lasting changes in dopaminergic function

Project Summary
The perinatal period is marked by intense plasticity, making it vulnerable to environmental factors that can derail
normal brain development and lead to maladaptive behaviors in the adult. High levels of serotonin during
development resulting from genetic manipulations, maternal inflammation or administration of selective-
serotonin-reuptake-inhibitors (SSRIs) lead to alterations in brain development and/or to behavioral deficits in
adult rodents such as anhedonia, anxiety-like behaviors and social interaction deficits. In our preliminary work,
we have found that increasing serotonergic tone during the perinatal period leads to decreased exploration,
decreased response to an amphetamine challenge and motivation deficits. Interestingly, these behaviors are
dependent on the dopaminergic system, a known regulator of mood, reward seeking and motivated behavior.
During development, the serotonergic system develops earlier than the dopaminergic one and the Dorsal Raphe
nucleus projects strongly to the Ventral Tegmental Area, enabling the serotonergic system to modulate the
dopaminergic one. While most studies have focused on the effects of abnormal developmental serotonin levels
on the serotonergic system itself or on cortical development, how it affects the dopaminergic system and function
is unknown. We hypothesize, based on preliminary data, that high levels of serotonin during development disturb
dopaminergic function through the Dorsal Raphe > Ventral Tegmental Area > Nucleus Accumbens pathway
resulting in behavioral deficits in the adult. Using a combination of behavioral testing, optogenetics and
electrophysiology, we will assess how elevated serotonin levels during development affect our target
dopaminergic circuit. In Aim 1, we expand on our preliminary data to characterize the extent to which dopamine-
dependent behaviors are affected in mice exposed to SSRIs during the perinatal period. In Aim 2, we delineate
the molecular, cellular and circuit bases of the deficits in dopamine-dependent tasks observed in our preliminary
data. Understanding the regulation and the interactions between serotonin and dopamine in this key
monoaminergic circuit can have clinical implications spanning from mood disorders to autism and motivational
aspects of behavior. Furthermore, although our serotonergic manipulation is optimal from experimental and
neurobiological perspectives, it is also potentially relevant to real-world clinical situations. Indeed, some
pregnancies require the use of antidepressants, which typically increase fetal serotonin levels. An enhanced
understanding of the behavioral consequences and the mediating mechanisms of early elevations in
serotonergic levels may have substantial implications for improving the lifelong outcomes of the offspring of such
pregnancies in the future.

Public health relevance
Project Narrative Many neuropsychiatric disorders have developmental origins in which susceptibility to disease is restricted to narrow developmental windows; the perinatal period is a highly plastic time in which environmental factors can derail the normal development of the brain. Serotonin and dopamine are two key regulators of mood, reward- seeking and motivated behavior; several environmental factors have been shown to alter serotonin levels during development and lead to behavioral deficits in the adult. In this study we will explore how changes in serotonin levels during development affect the dopaminergic system because understanding changes in this neuronal circuit following developmental insults is key to preventing/treating behavioral deficits later in life.